CORE--ENRICHMENT PROGRAM

Description (taken from application): The purpose of this program is to facilitate the exchange of information between investigators who have research interests in the areas of diabetes and hormone action. The Enrichment Core has utilized six approaches to achieve this goal: 1) guest speakers program, 2) yearly symposia, 3) workshops, 4) individual research data clubs, 5) insulin-IGF research group meetings and 6) signal transduction research group meetings. This format has proven to be highly successful as it involves all members of the DERC at several levels of information interchange.